Disturbed Crosstalk between Cholesterol Homeostasis and Inflammation Resolution in NASH

Project Summary/Abstract
Non-alcoholic steatohepatitis (NASH) has emerged as the leading cause of chronic liver disease worldwide, with
liver fibrosis as the most important predictor of morbidity and mortality in NASH. However, due to the major gaps
in understanding the mechanisms of NASH progression, particularly fibrosis, there are no FDA-approved drugs
to treat NASH and halt the progression of NASH to cirrhosis and hepatocellular carcinoma. Emerging evidence
shows that excessive cholesterol accumulation in hepatocytes promotes liver fibrosis in NASH, but how hepatic
cholesterol homeostasis is disrupted during NASH is not completely understood. Human genome-wide
association studies (GWAS) have indicated that EH domain binding protein 1 (EHBP1) is associated with low-
density lipoprotein (LDL) cholesterol levels, and single-cell RNA sequencing (scRNA-seq) of human livers has
revealed that EHBP1 expression is dramatically reduced in hepatocytes from cirrhotic livers with advanced
fibrosis, indicating that hepatocyte EHBP1 may play a role in liver fibrosis through modulating cholesterol
metabolism. The overall objective of this proposal is to study the role and the regulation of EHBP1 in NASH. Our
studies with primary human and mouse hepatocytes showed that EHBP1 deficiency enhances LDL receptor
(LDLR), cellular cholesterol, and the Hippo pathway effector TAZ, a novel cholesterol sensor that can induce
liver fibrosis in NASH. We further found that hepatocyte-specific silencing of EHBP1 induces liver LDLR,
cholesterol, TAZ, and liver fibrosis in NASH mice. We recently published that hepatic cholesterol stabilizes TAZ,
and therefore propose that hepatocyte EHBP1 reduces liver fibrosis by preventing cholesterol accumulation and
suppressing TAZ in NASH (Aim 1). Our study supports a role of EHBP1 in cholesterol homeostasis to prevent
liver fibrosis in NASH. However, as NASH progresses, EHBP1 expression is reduced. Surprisingly, we found
that the NASH-relevant inflammatory cytokine TNFa significantly suppresses the expression of EHBP1 and
PPARa, a predicted transcriptional regulator of EHBP1, in primary hepatocytes. Hence, we propose that
inflammatory stress caused by TNFa disturbs cholesterol homeostasis by suppressing PPARa/EHBP1
expression in hepatocytes during NASH (Aim 2). We further found that TNFa-suppressed EHBP1 can be blocked
by treatment with resolvin D1 (RvD1), a docosahexaenoic acid (DHA)–derived specialized pro-resolving
mediator (SPM) that can trigger resolution of inflammation. As RvD1 is produced by macrophages, we propose
that macrophage-derived RvD1 blocks TNFa-mediated EHBP1 suppression in hepatocytes and this RvD1-
mediated cellular crosstalk maintains cholesterol homeostasis and prevents fibrosis in NASH (Aim 3). As the
beneficial effects of SPM analogues have been tested in clinical trials for other inflammatory diseases, our study
elucidating the crosstalk between inflammation resolution and cholesterol homeostasis will provide insights on
the potential use of RvD1 analogues as an innovative therapeutic strategy for NASH.

Public health relevance
Project Narrative Cholesterol accumulation is critical for the pathogenesis of nonalcoholic steatohepatitis (NASH) with fibrosis, a rising public health threat with no available drug treatment. This proposal aims to study the role of the cholesterol- associated GWAS locus EHBP1 in liver fibrosis in the context of NASH and explore the novel crosstalk between EHBP1-mediated cholesterol homeostasis and inflammation resolution. Successful completion of our proposed studies will help meet the critical clinical need for novel therapies that can prevent NASH progression to fibrosis.